Administrative Core

PROJECT SUMMARY
The Administrative Core is responsible for the implementation of the Pacific Island Partnership for Cancer
Health Equity (PIPCHE). This is achieved through continued leadership, coordination, integration, and a
longstanding infrastructure designed to facilitate administrative management, communication, and rigorous
team science; promote integration; and oversee research progress to achieve PIPCHE’s overarching goal: to
promote cancer health equity and mitigate the impact of cancer on Pacific Island Populations (PIP) through
increasing cancer research leadership and capacity in Hawai‘i, Guam, and the USAPI. The Administrative
Core (AC) will implement all aspects of the Partnership, including coordinating and planning all meetings and
workshops including monthly PIPCHE Team meetings and Executive Committee (EC) meetings, Internal Team
Meetings, as needed, quarterly Internal Advisory Committee (IAC) meetings, yearly Program Steering
Committee (PSC) meetings and Scientific and Planning Workshops; biennial Retreats, semiannual Community
Advisory Board meetings, comprehensive PIPCHE evaluation through the Planning and Evaluation Core,
preparation of the annual progress reports for the PSC and the annual noncompetitive application for the NCI,
and working with institutional leadership regarding recruitment, fiscal management, and resource allocation. In
addition, the Administrative Core functions as the primary liaison to the NCI, PSC, and IAC, and is responsible
for communicating and advancing their recommendations. By serving these functions, the Core will allow
investigators to focus on conducting and disseminating regionally-relevant and culturally appropriate research
supported by PIPCHE.